Mechanisms of olfactory neuroblastoma tumorigenesis

Our laboratory is focused on understanding how and why head and neck cancers develop in the nasal cavity, sinuses, and base of the skull. We seek to translate these results into better therapies. We are particularly interested in a type of cancer called olfactory neuroblastoma (also known as esthesioneuroblastoma), which researchers think arises from the olfactory epithelium, the area of the nose important for the sense of smell. Our laboratory utilizes a variety of in vitro and in vivo experimental approaches and immunotherapeutic and other treatment platforms to achieve these goals. We are actively developing a series of clinical trials to improve treatment effectiveness and survival in patients with sinonasal and skull base cancers.